Molecular Virology and Systems Biology Screening Core

This program project seeks to systematically address crucial questions about the interplay between innate responses to HIV-1 infection. We anticipate to dissect the complete repertoire of cellular sensors and effectors involved in the innate signaling pathways that respond to HIV-1. Moreover, the rate-limiting components and the crosstalk between these pathways will provide critical information about important key players in the response to HIV-1. We also anticipate to acquire a novel understanding of the kinetics of HIV-1 infection regulated by these pathways and the effect of these pathways on the clinical outcome of infection. The systems-level understanding of these processes will be used to construct mathematical models that can predict the behavior of these pathways to HIV-1 infection. These integrated pieces of information about the host-pathogen interface will be invaluable for future optimization of antiviral and vaccine approaches. Scientific projects taking place within the scope of the Program Project will rely to a great extent on largescale production of viruses and siRNA, shRNA and cDNA technologies in high-throughput format as a result of the genomics nature of the approach. The goal of the Molecular Virology and Systems Biology Screening Core is to support the scientists in all aspects ofthe large-scale and system-biology screening approaches by providing state-of-the-art cellular genomics technologies and molecular virology tools. The PI has significant experience in the field of systems-biology. Dr. KOnig will provide her collective expertise in Virology for over 11 years and her experience in developing and employing systems-biology screening tools. These studies are expected to provide global molecular insight into cellular and viral processes that regulate early immune responses to HIV infection.

Public health relevance
These studies will enable a global understanding ofthe cellular immune response to HIV infection, and will provide the basis for the development of novel therapeutics and vaccines.